Ex vivo and In vivo Model Advancements for Airway Stent Design Optimization

PROJECT SUMMARY
Tracheobronchomalacia is a rare disease involving excessive airway collapse due to weakening of the airway
walls. It is diagnosed in 13% of adults and 30% of children who undergo bronchoscopy for respiratory distress.
The disease is characterized by the percentage collapse and collapse-morphology in the weakened airway
segment. The collapse-morphology can vary depending on the relative anatomical region(s) of tissue weakening.
Mild to moderate Tracheobronchomalacia can be treated non-invasively via positive pressure ventilation. Positive
pressure ventilation, while noninvasive, requires the patient to be attached continuously to a pressure generating
device for effective treatment. Severe Tracheobronchomalacia usually requires surgical intervention that involves
attaching supportive materials outside the trachea that thwarts regional collapse. Surgical interventions are
complex and require long post-operative recovery. Airway stents provide a simple, economical and minimally
invasive treatment mode. Unfortunately, available stents are avoided or only implanted for monitored short
periods due to stent-associated complications of excessive granulation tissue formation and mucus plugging
resulting from the foreign body reaction against the implanted stent. Stent physical characteristics play a
significant role in inducing excessive granulation tissue formation and mucostasis. The stent physical
characteristics which include the stent material, geometry and size, need to be optimized at the design and
development stage to minimize the physical impact during implantation. Existing benchtop and animal models
can neither reliably generate the grades and morphologies of Tracheobronchomalacia, nor do they possess the
granularity needed to perform design optimization. In this proposal we will establish new research tools and
protocols that will substantially advance the stent design process and propel the development of viable airway
stents. We present the first benchtop platform for rapid stent testing capable of generating specific grades and
morphologies of Tracheobronchomalacia and accurately simulate dynamic airway collapse. Our system
evaluates stent effectiveness in the clinically relevant parameter of airway lumen cross-sectional area.
Furthermore, the platform can map the device-to-airway contact force distribution during dynamic airway
collapse. In aim 1, we will first establish the protocols for reliably generating the clinical grades of
Tracheobronchomalacia. Next, we will evaluate the performance of helical and axial stent designs of varying
geometric feature values. This will determine the geometric parameter for each stent design for treating
Tracheobronchomalacia using minimum material and contact forces. In aim 2, we will study the effect of stent
geometry and oversizing on the spatial distribution and severity of granulation tissue formation and mucostasis.
At the conclusion of experiments from both aims, we will attempt to establish a relationship between the spatial
characteristics of granulation tissue recorded from the animal study and the benchtop contact forces. This will
enable assessing stent designs prone to granulation tissue complications before testing stents in animals.

Public health relevance
PROJECT NARRATIVE Excessive airway collapse due to the weakening of airway walls impedes respiratory gas exchange. Available airway stents can be used for only short periods due to severe side effects, and patients need to either remain attached to a CPAP machine all day or undergo major surgery involving a long recovery. To propel the development of viable stents we are proposing a superior benchtop airway platform capable of accurately simulating the diseased condition and perform rapid stent testing with high granularity.